Development of heparan sulfate-based therapeutics to treat inflammatory diseases

Abstract
More than 60 million Americans consume acetaminophen (APAP) on a weekly basis.
Unfortunately, an overdose of APAP causes liver toxicity and is responsible for over half of acute
liver failure cases in the US. N-acetyl cysteine is the only antidote for APAP overdose and is
effective if given within 10 hours after APAP ingestion. However, many patients don’t seek out
treatment during the therapeutic window for N-acetyl cystine. Currently, a liver transplant is the
only available treatment option for these late-presenting patients. APAP toxicity is a leading cause
for liver transplantation in the US and worldwide.
The goal of this SBIR phase II project is to develop an anti-inflammatory synthetic heparan sulfate
oligosaccharide, GLY-202, for APAP overdose patients specifically late-presenting patients. GLY-
202 was selected after compound optimization studies in efforts to identify a smaller, easier to
synthesize oligosaccharide with in vivo efficacy compared to 18-mer in the APAP overdose model.
Unlike 18-mer, the synthesis of GLY-202 can be achieved in a shorter synthetic route,
substantially decreasing the production cost and reducing a significant commercialization barrier.
This application for TABA funding is to support consulting work to progress GLY-202 for a Type
B (pre-IND meeting) which will heavily influence our IND. The success of this project will provide
a new approach to treat drug induced liver toxicity by targeting to HMGB1-mediated inflammation
with a first-in-class therapeutic.

Public health relevance
Project Narrative GLY-202 is being developed for drug induced liver injury. In this application for TABA funding, we are requesting support for consulting to help us write our pre-IND briefing booklet and design the clinical studies.